Clinical factors associated with long-term recovery following pediatric critical illness and injury

PROJECT SUMMARY/ABSTRACT
As pediatric trauma mortality in the United States has declined over the past several decades, children
are surviving after increasingly severe injuries. Many children surviving severe trauma experience prolonged
impairments in quality of life, function, and psychosocial health. Existing studies have only evaluated how injury
characteristics affect morbidity; it is unknown whether any modifiable factors influence long-term outcomes.
Critically injured children often experience medical complications of their initial injury with prolonged treatment
in the intensive care unit, and thus there may be components of their clinical course that contribute to morbidity
beyond the effects of the injury alone. Identification of these clinical factors may provide targets for
improvement in critical care management in order to optimize recovery from severe pediatric trauma.
The long-term career goal of the K23 candidate, Elizabeth Killien, MD, MPH, is to build an
independently funded research program to develop interventions to improve long-term outcomes among
critically injured children. Her proposed research project will evaluate the contribution of a variety of clinical
factors to long-term deterioration in health status after pediatric trauma. The specific aims are to 1) evaluate
how the longitudinal trajectory of post-discharge recovery differs among children surviving critical injury
compared to other acute illnesses; 2) determine which clinical exposures are associated with outcomes for
trauma compared to other acute illnesses; and 3) assess the generalizability of the important clinical exposures
identified locally in a multicenter national trauma cohort. These objectives are consistent with the priorities of
the Pediatric Trauma and Critical Illness Branch of NICHD to conduct “multidisciplinary research across the
continuum of care” to understand “the long-term impact of trauma on child health outcomes.”
To acquire the skills necessary to accomplish this project and subsequently develop an R-series
proposal, Dr. Killien will undertake didactic and experiential training to 1) develop expertise in multi-
dimensional, longitudinal assessment of post-hospitalization outcomes; 2) gain experience with prospective
study design and management and collaboration with research networks; 3) acquire skills in advanced
statistical methods; and 4) facilitate her transition to independence. Dr. Killien has assembled an
interdisciplinary mentorship and collaborator team with expertise in pediatric trauma, critical care, organ
dysfunction, outcomes assessment, and statistical methodology to ensure completion of the proposed
research and training and a successful transition to independence. Her research and training will be conducted
at the University of Washington's Harborview Injury Prevention and Research Center. The proposed award will
augment Dr. Killien's existing strengths in outcome assessment after critical illness and provide the additional
training necessary for her to become an independent investigator in pediatric critical care medicine.

Public health relevance
PROJECT NARRATIVE Traumatic injury contributes to more deaths among children and adolescents in the United States than all other causes combined, and is the leading cause of preventable morbidity in pediatrics with over 100,000 children a year at risk of experiencing long-term impairments after severe injury. The goal of this proposal is to identify potentially modifiable post-injury clinical factors that contribute to poor long-term outcomes after pediatric trauma. Improving clinical management after an injury has occurred in order to optimize recovery may complement injury prevention efforts to reduce the overall burden of severe traumatic injury in children.